ALPHA-FETAL PROTEIN AND PROLACTIN IN LUPUS PREGNANCY

Prolactin is an immune activator that is associated with active lupus in the murine model. We investigated whether these are predictors of preterm birth in systemic lupus erythematosus.